Diagnostic Accuracy through Advancing EHR displaY, Education and Surveillance (DATA-EYES)

Project Summary:
Diagnostic error (DE) remains one of the most costly and prevalent forms of preventable medical error, with nearly
12 million Americans affected annually at an estimated cost of over $100 billion. Unfortunately, efforts to reduce DE have
remained largely unsuccessful. This is in large part due to the fact that etiology of DE is highly complex with multiple
contributing factors. However, central to the diagnostic process are critical cognitive processes such as the physician's
ability to find and process relevant information, reason with this information, and formulate a diagnosis. With over 95%
of healthcare providers adopting electronic health records (EHRs), these systems are the primary source of nearly all
patient information and, therefore, shape the diagnostic process. While it is recognized that the EHR contributes to the
problem of DE, the identification and relative contribution of how, when and why the EHR contributes to DE, specifically
as it relates to the sociotechnical domains of software, user and system (workflow) are poorly described. We have
attempted to better define this through the analysis of medical malpractice cases (CRICO) and patient safety event (PSE)
report forms related to DE in ambulatory care. From our medical malpractice analysis, nearly 60% of cases of DE had a
definitive EHR contribution, with another 19% indeterminate. The EHR contributed most often during the testing phase
of the diagnostic process with the most common EHR hazards related to data interpretation, order placement and
execution of plan. However, this analysis relies on manual evaluation of unstructured data which is highly time consuming,
lacks specificity and is impractical for widespread adoption. Once the relative contribution of EHRs to DE can be
determined, health systems can then deploy solutions to help mitigate. Ideally this will include the ability to use simulation
to guide both EHR redesign and training, in situ observation of how the EHR integrates into daily workflow and a strategy
to monitor the impact of these interventions. The goal of this proposal is to establish a Diagnostic Center of Excellence
(DATAEYES) focused on identification of EHR contribution to DE, and use this information to deploy a suite of solutions to
improve software, user and system. We will achieve this by using national data to create an informed taxonomy to be
integrated into institution data collection tools, to facilitate institution-wide capture of EHR contributions to DE in Aim #1.
We will then develop and validate these tools in Aim #2 and use this information, in combination with in situ workflow
observations, to inform how, when and why the EHR is contributing to DE. This information will be used to create high-
fidelity simulated EHR charts to facilitate both workflow specific training on EHR best practices and guide EHR redesign
and monitor the impact of these interventions via EHR audit logs in Aim #3. The 3 centers participating (OHSU, Medstar
Health, Brigham and Women's Hospital) will allow further ascertainment of the impact of both EHR vendors being studied
(Cerner and Epic) and local workflow specific practices. We will then leverage our collaborations with patient safety
organization and industry to disseminate these findings and the infrastructure developed at DATAEYES will serve as a core
resource for the other DCE sites, allowing for rapid evaluation and prototyping of future EHR based solutions.

Public health relevance
Project Narrative Diagnostic error remains one of the most prevalent forms of preventable error and one strategy to address this requires a multipronged approach to improve provider access to, and processing of, clinical information. The Electronic Health Records (EHR) is the main source of clinical information, with poor EHR use and design being key contributors to diagnostic error, although the ability to understand how, when and why the EHR contributes to diagnostic error to create effective solutions is severely limited by the lack of standardized tools for collecting this information. The goal for our Diagnostic Center of Excellence, DATAEYES, is to establish an infrastructure to systematically collect data on how, when and why the EHR contributes to diagnostic error and use this information to create a series of interventions aimed to address lacunae in training, software and workflow to standardize, and optimize EHR use to achieve diagnostic excellence.